VAST Center: Viromes Across Space(s) and Time

DATA ANALYSIS CORE ABSTRACT
Our Data Analysis and Submission Core (DASC) proposal builds a unified system for human
virome research that seamlessly integrates advanced computational tools to ensure the reliability
and accessibility of datasets and processed results. Our research strategy encompasses three
main objectives: First, it aims to develop a robust computational infrastructure that includes
implementing cutting-edge systems, standardizing data and metadata protocols, and adhering to
standardized operating procedures, all essential for enhanced data analysis. Second, the
proposal focuses on integrating cross-validation, data interpretation, and preliminary studies,
emphasizing the development of consistent and reliable analytic methods, undertaking an in-
depth analysis for a profound understanding of the human virome, and conducting extensive
preliminary studies across varied demographics. The third objective is to enhance the process of
data submission and increase the accessibility of virome research data by developing user-
friendly platforms, ensuring comprehensive data submission in compliance with consortium
agreements. Our plan involves conducting systematic surveys of human viromes across diverse
individuals and body sites, employing robust bioinformatic tools and methodologies for evaluating
viral communities and quantifying viral species identification confidence. This approach is pivotal
in advancing our understanding of the human virome, setting new benchmarks in data analysis,
standardization, and dissemination of virological research. Overall, our DASC proposal is a
groundbreaking initiative, aiming to significantly advance human virome research through
innovative data analysis, standardization, and accessibility, it aspires to merge the molecular data
types generated by the Virus Characterization Centers (VCCs) into a unified computational
framework, quantifying viral richness and variation across demographically diverse human
populations and different body sites, thereby paving the way for future innovations and
applications that can profoundly impact human health and disease management.